Developmental sleep disruption interacts with underlying CHD8 genetic vulnerability in autism spectrum disorder

PROJECT SUMMARY
Autism spectrum disorder (ASD) is a common neurodevelopmental condition that affects social behavior and
cognitive flexibility. Sleep disruption is a common comorbidity in ASD, observed in more than 80% of affected
individuals. It has been debated whether sleep disruption in ASD is a consequence of altered brain function, or
whether sleep disruption is actually a core component of ASD and driver of altered brain function and behavior.
Sleep disruption is often seen in advance of ASD diagnosis, and the severity of sleep disruption can be
predicative of the severity of other ASD associated phenotypes, strongly suggesting that sleep disruption is an
early symptom in ASD and a potential driver of the condition. Multiple studies, including new work from our lab,
have shown in animal models (rodents and fruit flies) that a period of early life sleep disruption is causal in long-
lasting and sex-specific changes in social and cognitive behaviors in adults. Thus, developmental sleep
disruption is emerging as an important contributor to ASD susceptibility. Alterations in synapse number,
structure, and function have been documented repeatedly in ASD models and patient samples, leading many to
describe ASD as a “synaptophathy”: a dysfunction of synapse function. Consistent with this assertion, gene
sequencing efforts have identified hundreds of risk genes associated with ASD, many of which encode proteins
with known synaptic functions, such as the excitatory synaptic scaffold protein SHANK3. Another important
cluster of ASD risk genes encode for proteins with nuclear functions such as CHD8. Sleep has been shown to
be critical for synapse formation, maturation and elimination in the developing brain. Therefore, we hypothesize
that synapse maturation is a critical vulnerability to the consequences of developmental sleep disruption. We
have recently published that early life sleep disruption (ELSD) can cause long-lasting and sex-specific changes
in behavior in the genetically vulnerable Shank3(+/C) heterozygous mice, whereas wild type littermates were
found to be resilient (Lord et al., 2022, Molecular Autism). To determine if developmental sleep disruption is
broadly relevant in ASD we must test whether ELSD similarly interacts with distinct genetic vulnerabilities. CHD8
is a high-confidence ASD risk gene that encodes a nuclear chromatin remodeling enzyme. CHD8 is believed to
play an important role in brain development during embryogenesis, but whether CHD8 mutation also confers
vulnerability to postnatal sleep disruption has not been tested. We will determine whether ELSD drives lasting
changes in behavior in genetically vulnerable Chd8(+/V986*) ASD model mice, similarly to what we have recently
demonstrated with heterozygous Shank3 ASD model mice. We will also examine whether postnatal synapse
maturation is a convergent node of vulnerability to developmental sleep disruption. Our goals in this R21 proposal
is to establish developmental sleep disruption as an important risk factor contributing to ASD susceptibility by
interacting with diverse underlying genetic etiologies, and to develop methodologies to pursue the developing
synapse as a convergent node of vulnerability to the effects of sleep disruption in ASD.

Public health relevance
PROJECT NARRATIVE Early life sleep disruption is common in autism spectrum disorder and has been shown in animal models to cause lasting changes in brain function and behavior. Treatments for sleep disruption in children are extremely limited, and the basis for vulnerability to early life sleep disruption is not known. Here we will test whether mutation in a known autism risk gene confers vulnerability to the effects of developmental sleep disruption, and whether the developing synapse is a node of vulnerability to the effects of sleep disruption.